Cancer Research Training and Education Coordination

CANCER RESEARCH TRAINING AND EDUCATION COORDINATION – ABSTRACT/SUMMARY
Training the next generation of cancer researchers and leaders is a core mission of Yale Cancer Center (YCC).
YCC has a long track record of providing infrastructure and funding for enhancing trainee research and
advancing the careers of trainees and faculty across all YCC disciplines, including basic, translational, clinical
and population sciences. YCC-supported education efforts have contributed to successful careers of trainees
with diverse backgrounds, from students through senior faculty. The Cancer Research Training and Education
Coordination (CRTEC) Council, which supports and advises CRTEC leadership includes representation from all
six YCC research programs as well as the Associate Directors for Diversity, Equity and Inclusion and Community
Outreach and Engagement (COE), ensuring broad, cross-disciplinary input and training and supporting the
major goal of CRTEC, to bolster and coordinate training activities across disciplines providing cancer-specific
training while leveraging the vast resources of Yale University and Yale School of Medicine (YSM). The CRTEC
Council reviews classes and other training vehicles in the various training programs and integrates trainees at
all levels into programmatic activities via their association with one of the six YCC Research Programs. Specific
CRTEC activities include building training capacity; monitoring success; coordinating existing YCC education
activities to maximize synergy and avoid redundancy; and providing additional opportunities by sponsoring
seminars, workshops, and travel to scientific meetings; providing mentoring on proposal and career
development; providing training in research of underserved populations; recruitment of women and
underrepresented minorities (URM), and monitoring metrics for success. YCC and YSM have multiple cancer-
specific and cancer-related training grants for high school, college, pre- and postdoctoral trainees and junior
faculty. Currently, YCC 10 cancer-specific institutional training grants supporting trainees working with YCC
Mentors. In addition, there are multiple active individual F and K awards from the NCI. The CRTEC Council
reviews YSM training programs annually and identifies opportunities to integrate cancer-specific training into
YSM activities and provide a cancer focus. An important goal is integration of training and education across
disciplines: basic, preclinical, and clinical science, epidemiology, and outcomes. These elements are very strong
individually and benefit from increased integration that encompasses nursing, medical, and graduate students,
postdoctoral trainees, residents, fellows, and faculty in cancer-related disciplines. Our Aims cover the spectrum
of trainees from school-age through post-baccalaureate and master-level trainees (Aim 1), pre- and post-doctoral
trainees (Aim 2) and junior to mid-career faculty (Aim 3). We incorporate iterative evaluation processes to
improve our programs and monitor trainee diversity and training outcomes.

Public health relevance
CANCER RESEARCH TRAINING AND EDUCATION COORDINATION – NARRATIVE Not applicable.